A Mechanistic Study to Investigate tDCS and Working Memory in MCI Patients

Project Summary/Abstract
This K25 proposal is for a five-year mentored training program to launch Dr. Aprinda Indahlastari’s career as an
independent aging investigator by leveraging her engineering background to develop personalized cognitive
intervention in NIH-relevant research on cognitive aging and dementia. As such, the proposed training will
transition Dr. Indahlastari into the field of aging and ADRD, by 1) acquiring knowledge in neurobiological effects
of clinical aging and Alzheimer's disease and related dementias (ADRD) in the context of aging interventions, 2)
gaining experience in clinical trial design focused on deploying aging interventions, 3) learning skills in advanced
neuroimaging analytics with machine learning to probe and analyze intervention effects, and 4) becoming an
independent investigator and forming a network of collaborators in clinical ADRD research. The training plan
encompasses various components such as formal coursework, didactics, clinical cases shadowing, conferences,
direct mentorship, and career development activities to facilitate candidate’s transition towards independence.
The overarching research question addressed in this proposal is characterizing the effect of acute (one-time)
application of transcranial direct current stimulation (tDCS) with standard fixed dosing on working memory
performance and functional connectivity in individuals with mild cognitive impairment (MCI). Fixed dosing
strategy refers to prescribing the same stimulation parameters to participants within a single study. To address
this question, a human trial study will be conducted at the University of Florida to evaluate working memory gains
with tDCS in MCI patients compared to healthy control. The study will employ state-of-the-art methods including
person-specific computational models, machine learning, and multi-modal neuroimaging. The research proposal
outlines two main aims to unravel the relationship between working memory gains and acute tDCS application
in the MCI cohort. Aim 1.) Identify whether acute tDCS application leads to greater behavioral change in working
memory and quantify important factors driving these changes in MCI patients compared to cognitively intact
cohort. We hypothesize that acute tDCS may increase working memory performance during active tDCS and
larger degree of brain atrophy and white matter hyperintensity observed in MCI patients will significantly
decrease current intensity in stimulated brain regions. Aim 2.) Determine whether acute tDCS application
strengthens functional connectivity within the working memory network. We hypothesize that acute tDCS may
significantly increase functional connectivity within the working memory network during active stimulation, but
not during sham stimulation, for both healthy and MCI cohorts. Machine learning enhanced models will be
employed to identify important tDCS current characteristics that drive working memory gains and strengthen
connectivity networks at individual level. The information gathered from this grant will provide a basis for future
R01 submission to formulate custom intervention tailored to each individual. These personalized interventions
are expected to be more effective than the standard fixed dosing strategy in improving overall cognitive abilities.

Public health relevance
Project Narrative Working memory, a sub-cognitive domain that provides temporary storage of memory to perform complex cognitive tasks, is essential for maintaining activities of daily living and one of the first functions to decline in older adults with cognitive impairments including Alzheimer’s disease and related dementia. The proposed project and the training components associated with this project will examine working memory gains induced by transcranial direct current stimulation (tDCS) as a cognitive intervention method in cognitively healthy and impaired cohorts. Results from this study will promote a better understanding of mechanistic properties underlying working memory gains with tDCS and guide future intervention strategies to combat cognitive decline and improve the quality of life of aging and dementia populations.